Prevention Core

The Johns Hopkins University (JHU) CFAR's Prevention Core (PC) aims to sustain a culture
and community that broadens and strengthens existing professional networks, transcends the
practical and theoretical silos that increasingly defined HIV research at Johns Hopkins and
support collaborative, innovative HIV preventive investigation by identifying the barriers to
collaboration that exist at an individual, network and system level and deliberately employ a
series of mechanisms, including events and programs, to spark innovation, collaboration, and
discourse among colleagues with disparate expertise and experience.
The JHU PC will invest considerable resources into identifying the overall and specific needs of
early stage investigator (ESI) faculty using surveys, brown bag lunch meetings, one-on-one
conversations and sustained mentoring. The PC offers ESI faculty comprehensive, responsive,
and rapid guidance that acknowledges shifting NIH priorities and emerging scientific findings
along with mentorship and opportunities to establish independent NIH research careers